Precision administration of anti-thymocyte globulin with or without verapamil in adolescents and young adults with type 1 diabetes

PROJECT SUMMARY/ABSTRACT
Insulin is a replacement, not a curative, therapy in the management of type 1 diabetes (T1D) which is caused
by loss of immune tolerance and destruction of pancreatic beta cells. More recently, beta cell stress has also
been found to contribute to T1D pathogenesis. Despite this knowledge, no disease-modifying therapies
(DMTs) have been approved for the treatment of symptomatic T1D. A T cell specific immune therapy, anti-
thymocyte globulin (ATG), in low doses, has been shown to lower HbA1c and preserve endogenous insulin
production (measured by C-peptide) in individuals with recently diagnosed T1D. However, not all individuals
who received ATG responded to the therapy. A portion who received drug had a similar decline in C-peptide
as the placebo-treated individuals. Another monotherapy in T1D shown to preserve C-peptide, Verapamil, is
a calcium channel blocker and is proposed to reduce beta cell stress.
To advance our long-term goal, to directly inform the development and translation of DMTs in those with
T1D in a precision-directed manner, this proposal seeks to address three gaps in the field: (1) identification
of who is most likely to “respond” to ATG prior to drug administration, (2) use of sequential therapies to
increase efficacy using both immunomodulatory and beta cell protective therapies, and (3) clinical trial design
to assess efficacy earlier than the standard endpoint at 1 year allowing for shorter trials.
This proposal includes a randomized, placebo-controlled, and blinded trial. Using a predictive biomarker
of response to ATG we developed, participants with T1D will be stratified as “responders” and “non-
responders.” This study will be powered to detect a difference at the standard 12-month time point and a
novel 6-month endpoint to allow for validation of both an adaptive trial design and responder signature. Such
a signature was developed by our group using data from a large ATG in T1D clinical trial. To address the beta
cell-specific disease mechanism, at 1-year participants will be re-randomized to take verapamil or not for an
additional year. To understand the driving mechanisms of each therapy and their potential synergy, we will
perform in depth immunophenotyping and quantify biomarkers of beta cell stress and abnormal prohormone
processing, as verapamil has been shown by us and others to not only affect beta cell stress but also T cell
subsets. Our central hypothesis is that population enrichment via our novel ATG responder prediction
tool will dramatically enhance C-peptide preservation following ATG which will be prolonged with
verapamil via immune-specific mechanisms.
Completion of these aims will prospectively validate the utility of responder immune profiling, alternative
trial designs, and synergies emanating from the use of unique and potentially complimentary therapies in
T1D. Ultimately, these efforts seek to accelerate approval of repurposed disease-modifying precision-directed
therapies for T1D.

Public health relevance
PROJECT NARRATIVE Despite successes in recent-onset type 1 diabetes disease-modifying trials, drug approvals remain out of reach due to non-responders inhibiting drug efficacy, lengthy trial durations, and failure to target both immune and beta cell-specific mechanisms of T1D pathogenesis. We developed a novel responder immune signature to low dose anti-thymocyte globulin to direct enrollment in our randomized controlled trial that will also test early and standard T1D clinical trial endpoints. This will be followed by a potential beta cell protective therapy, verapamil, to understand mechanisms of synergy and extend treatment efficacy.